Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
The Vision Research Core Grant (VRCG) includes five Cores (Software Engineering Core, Molecular Construct
and Packaging Core, Microscopy and Tissue Processing Core, Small Animal Ocular Imaging Core, and Large
Animal Core) that provide services to meet the specific needs of a substantial cohort of NEI-funded vision
researchers at UC Davis. The Administrative Core ensures that these five Service Cores are run efficiently and
shared equitably among the Vision Research Core Grant participating investigators. The Administrative Core
communicates and coordinates VRCG services for maximum use, and it provides strategic plans to meet the
evolving needs of participating investigators. The Administrative Core also includes an evaluation plan to assess
Core impact and to promote continuous quality improvement.